THE XNAT IMAGING INFORMATICS PLATFORM

DESCRIPTION (provided by applicant): Imaging has emerged as one of the key tools used by biomedical investigators to further our understanding of human biology in health and disease. XNAT has emerged as the most widely used imaging informatics for supporting this research. We will develop the next generation of XNAT technology to support the ongoing evolution of imaging research. Development will focus on four key use cases: institutional repositories, clinical imaging research, multi-center trials, and data sharing. A variety of new capabilities wil be implemented, including deeper integration with clinical information systems, scalability services including integration with the cloud, on- demand access to statistical and other computational platforms, a GUI-based form building interface, configurable data feeds, and quality assurance and communications tools. These capabilities will be developed and evaluated in the context of real world scientific programs. A number of outreach and support activities targeted at XNAT users and developers.

Public health relevance
PUBLIC HEALTH RELEVANCE: Medical imaging is one of the key methods used by biomedical researchers to study human biology in health and disease. The imaging informatics platform described in this application will enable biomedical researchers to capture, analyze, and share imaging and related data. These capabilities address key bottlenecks in the pathway to discovering cures to complex diseases such as Alzheimer's disease, cancer, and heart disease.